Enhance the Capacity and Capabilities of Tennessee's Human and Animal Food Testing Laboratories in Support of an Integrated Food Safety System

Project Abstract
Technical Services Laboratory staff will work in support of an integrated food safety system.
Internal projects involving microbiology, special projects, and chemistry will be supported.

Public health relevance
Proposal Narrative Technical Services Laboratory (TSL) staff will support internal projects. Testing with a focus in the areas of chemistry, microbiology, and the development of new methods and special projects that expand testing will be a priority. The capacity and capabilities of Tennessee’s human and animal food Technical Services Laboratory will be enhanced.